Tumor Metabolism

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Tumor Metabolism, organized by Drs.
Eileen P. White, Joshua D. Rabinowitz, Marcia C. Haigis and David M. Sabatini. The conference is anticipated
to be held in Banff, Canada from February 6-10, 2022.
The field of tumor metabolism is one of the oldest in cancer biology, dating back to the seminal work of Otto
Warburg in the 1920s. Clinical importance of tumor metabolism is well validated by the successes both of
FDG-PET imaging and of antimetabolites as chemotherapeutic agents. The recognition that oncogenes both
promote the Warburg effect and activate anabolic pathways has provided impetus for revitalized examination
of tumor metabolism. This conference brings together leaders in tumor metabolism to discuss ongoing efforts
to understand and target metabolism of proliferating cancer cells and their support network. This conference
will address key questions regarding the metabolism of proliferating cells, the unique metabolic features of
tumors in vivo, and the associated opportunities for therapeutic intervention, including at the interface between
metabolism and immunotherapy. Key scientific questions that conference session will cover include (1) which
features of cancer cell metabolism are shared across proliferating cells, and which are cancer specific? (2) how
does signaling drive metabolism, and how does metabolism impact signaling and cell fate decisions? and (3)
what are the dependencies of tumors on host metabolism, and what is the impact of tumor metabolism on host
cells, including invading lymphocytes? By holding this meeting jointly with the Keystone meeting on
“Immunometabolism at the Crossroads of Obesity and Cancer” we aim to synergistically address how
overnutrition, the microbiome, and the metabolism of immune cells in the tumor microenvironment influences
that anti-cancer immune response. Through discussion of these and other questions, the conference aims to
generate new scientific ideas, promote collaborations, and enhance dissemination of the latest technologies
and best practices for metabolic studies. As the premier venue sharing important unpublished data in the tumor
metabolism field, this conference will help to accelerate scientific discovery and the development of new
strategies to treat cancer.

Public health relevance
PROJECT NARRATIVE The field of tumor metabolism is one of the oldest in cancer biology and the clinical importance of tumor metabolism is well validated by the successes both of FDG-PET imaging and of antimetabolites as chemotherapeutic agents. This conference will focus on the rapidly moving field of tumor metabolism and its implications to immunotherapy. By bringing together researchers in the field, this conference will help to accelerate scientific discovery and the development of new strategies to treat cancer.